TESTOSTERONE FEEDBACK REGULATION OF LH AND GH RELEASE IN YOUNG AND OLDER MEN

Many hormones have feedback actions on LH and GH production. Most notable is androgen's negative feedback on LH production and positive feedback on GH secretion. We hypothesize that androgen's time-dependent effects on LH and GH production are age dependent in men.